LONG TERM GROWTH HORMONE RELEASING HORMONE EFFECTS ON PITUIT. FUNCTION

To examine the influence of growth hormone releasing factor on pituitary growth hormone release and on linear growth in hypopituitary children.